Cancer Center Support Grant

DESCRIPTION (provided by applicant): The University of California San Francisco Comprehensive Cancer Center is an NCI-designated matrix center conducting a wide range of inter-disciplinary research in the areas of laboratory, clinical and population sciences integrating the activities of 331 members working at 4 major campus and hospital locations. Its goals are to: (1) support cancer research of the highest possible quality, in the areas of laboratory, clinical and population sciences; (2) develop patient outreach and education programs to increase the value of the Center to the local community; (3) promote and develop first-class care for cancer patients in our affiliated hospitals; and (4) create an integrated community of investigators dedicated to the shared goal of translating innovative science into improved clinical care. These goals are accomplished through the following 12 established Programs and 12 Shared Resources: Breast Oncology, Neurologic Oncology, Cancer & Immunity, Prostate Cancer, Chemistry & Cancer, Liver Cancer, Hematopoietic Malignancies, Cutaneous Oncology, Cell Cycling & Signaling, Cancer Genetics, Tobacco Control, Mouse Models of Cancer, Laboratory for Cell Analysis, Genome Analysis, Array, Tissue, Immunohistochemistry and Molecular Pathology, Transgenic/Targeted Mutagenesis, Biostatistics, Familial Cancer Risk, Informatics, Mouse Pathology, Molecular Epidemiology and Clinical Research Support Services.